Optimizing Efficiency and Quality of Brachytherapy for Cervical Cancer using Machine Learning Based Automation

Current treatment planning for brachytherapy of cervical cancer is performed with manual techniques that are
both time-consuming and subjective. Manual treatment planning takes 95 minutes on average and occurs
while patients are sedated, and the quality of the treatments is highly dependent on the expertise of the
physician. Unfortunately, the resource intensiveness and need for specialized expertise are barriers to
implementation of brachytherapy, and as a result many centers are not offering this essential treatment for
cervical cancer. Alarmingly, this rapid decline in brachytherapy utilization has been linked to 12% reductions in
patient survival. To overcome the barriers to delivering highly effective brachytherapy, there is a critical need
for tools that improve the efficiency and reduce the complexity of treatment planning for each patient. My long-
term goal is to become an independent investigator focused on automating brachytherapy cancer treatment
with machine learning, producing button-click solutions that will significantly upgrade the quality of
brachytherapy and combat declining utilization. I have significant experience in modeling, image processing
and computer programming and I want to build on this skillset with a training program that will prepare me for
independence. I have assembled an exceptional mentorship team, which includes expertise in machine
learning, clinical trials, implementation science and statistics. We formed a training plan to gain expertise in (1)
deep learning, (2) advanced statistical analysis, (3) design of clinical trials and implementation of technology
and (4) research career development. The research goal of this proposal is to develop a tool for fully
automated cervical brachytherapy treatment planning, which uses machine learning models to make
predictions for new patients. The central hypothesis is that automated planning using machine learning will
generate non-inferior or even superior plans in significantly reduced treatment planning time. This hypothesis
will be tested with the following specific aims: (1) Develop machine learning models, which use labelled patient
images to predict radiation dose; (2) Develop and evaluate efficacy of a pipeline for automated brachytherapy
planning; and (3) Prospectively measure the efficiency and clinical impact of automated brachytherapy
planning. For Aim 1, convolutional neural networks will be developed to predict 3D radiation dose from
imaging. Aim 2 will convert predicted doses into deliverable treatment plans using gradient-descent
optimization to determine optimal treatment parameters. Aim 3 will provide an end-to-end validation of the
automated planning by testing it in real-time clinical workflow. This work is innovative because it presents the
first clinical validation of an automated treatment planning system for brachytherapy of cervical cancer. The
proposed research is significant because it will revolutionize the current brachytherapy paradigm by applying
machine learning to automate and standardize time-consuming, manual processes. This work is a key step
towards my future R01 submission on multi-institutional implementation of automated cervical brachytherapy.

Public health relevance
Narrative: The proposed research is relevant to public health because automating high quality brachytherapy treatment planning for cervical cancer will improve the efficiency and reduce the complexity of brachytherapy. These tools could lead to improved patient outcomes by enabling more centers to offer the standard of care, decreasing sedation time, and reducing plan quality variations. This approach has the potential to automate brachytherapy planning for all types of cancer, beyond cervical cancer.